A novel mechanism for NLRP3 inflammasome activation in human macrophages

Infections and cellular stress can trigger cytoplasmic pattern recognition receptors to assemble an
inflammasome complex, which promotes the release of the inflammatory cytokines IL-1β, IL-18 and the
induction of pyroptotic cell death. Inflammasome responses are also perpetuated and propagated to bystander
cells. Ultimately, this response contributes to pathogen clearance and wound healing. However, excessive
inflammasome activation can contribute to- or cause debilitating symptoms associated with inflammatory
diseases. Particularly, the NLRP3 inflammasome has been directly linked to numerous diseases. It has a
unique position by not only sensing infections, but also cellular stress and tissue damage. Even though the
NLRP3 inflammasome is of utmost importance for balancing between homeostasis and disease, and is
therefore a prime target for novel treatment strategies, the underlying molecular mechanisms, particularly in
human macrophages, are still poorly understood. There are numerous human inflammasome components that
are absent in mice and their functional contribution to human health and disease are even less well understood
than the more conserved factors. Elucidating unique human responses is the main focus of our lab.
Innate immune receptor oligomerization initiates inflammatory host responses, including inflammasome
activation. The research outlined in this proposal is designed to mechanistically unravel a novel NLRP3
inflammasome activation concept in human macrophages. We discovered a novel NLRP3 inflammasome
component in human macrophages, which interacts with NLRP3, but is absent from mice and our preliminary
studies revealed that NLRP3 requires this co-sensor for oligomerization as well as for recruiting the
inflammasome adaptor, ASC. Furthermore, NLRP3 and its co-sensor are necessary for efficiently nucleating
ASC polymerization and caspase-1 activation. Knock out of the co-sensor phenocopies NLRP3 knock out in
human macrophages. Significantly, it is absolutely necessary for cytokine release driven by NLRP3 mutations
that cause Cryopyrin-Associated Periodic Syndrome (CAPS). We propose two specific aims that investigate
the mechanism and function of the co-sensor in NLRP3 inflammasome assembly and activation in
macrophages, as well as the molecular events that enable this co-sensor to promote NLRP3 inflammasome
activation. We will utilize CRISPR/Cas9 knock out and restored expression of wild type and mutant co-sensor
proteins and a humanized mouse expressing the human co-sensor for studying its function in vivo.
We expect that our research will uncover novel molecular mechanisms that not only change our current
understanding of control mechanisms that prevent inappropriate NLRP3 inflammasome activation for
maintaining homeostasis and human health, but also NLRP3-driven pathologies in inflammatory diseases.
The outcomes of our study will move the field forward and will be highly significant for understanding disease
pathologies and for the development of novel therapies that benefit patients and positively affect human health.

Public health relevance
Dysregulated NLRP3 inflammasome signaling causes detrimental pathologies of the expanding spectrum of sterile inflammatory diseases, including Cryopyrinopathies, Gout, Silicosis, Asbestosis, Atherosclerosis, Diabetes, Alzheimer’s disease, Cancer, kidney dysfunction and others. However, the mechanisms that control this NLRP3 inflammasome response are still poorly understood. In this application, we propose to define a novel identified NLRP3 binding partner, which is absolutely required for NLRP3 inflammasome activation specifically in human macrophages, which may provide novel targets for developing improved therapies for patients.